VACCINE AND EVALUATION TREATMENT UNITS

This program is comprised of a consortium of individual contracts within academic centers and organizations that provide a ready resource for the design and conduct of clinical trials to evaluate promising products to prevent and treat infectious diseases, such as Staphylococcus aureus. In general, products will be evaluated in normal healthy populations; however, access to special populations is also available.